Administrative Core

Administrative Core
Summary/Abstract
SD BRIN has been funded since 2001 as the BRIN/INBRE component of the NIH/NIGMS Institutional
Development Award program. The University of South Dakota Sanford School of Medicine partners with
one state-funded predominantly undergraduate institution (PUI), 4 private PUIs, and 2 tribal colleges in
SD BRIN. All of the partner institutions are small enrollment institutions ranging from 200 students
(Sisseton-Wahpeton College – tribal/outreach) to between 460 and 2,100 students (other private
partners) except for Black Hills State University (4,200 students). Thus, all partners have small numbers
of science teaching faculty that offer all courses and introduce scientific research to their students. Each
of our partner institutions have had large increases in research cultures including increases in faculty
members conducting research along with increase in undergraduate students interested in and
participating in research. In addition due to the cultural changes, the partner institutions have all found
other funds for remodeling or building new research spaces on their campuses and institutionalizing
more financial resources for supporting research faculty and students. Thus, SD BRIN has made major
changes in biomedical research infrastructure in South Dakota and is essential for maintaining the strong
research and pipeline for research careers initiatives that it has established and facilitated.